92 KDA TYPE IV COLLAGENASE INCREASES DURING EXPERIMENTAL INTRAUTERINE INFECTION

Maternal genital tract infections have been associated with the development of premature rupture of the membranes (PROM) and preterm labor. It has been suggested that infection triggers a cytokine cascade that participates in the pathogenesis of PROM. Recently, we demonstrated the overexpression of matrix metalloproteinases (MMPs) in human amnion-derived cells induced by tumor necrosis factor (TNF-`). Increased expression of MMPs in chorioamnion has been proposed as a mechanism of PROM. Three pregnant rhesus monkeys were chronically catheterized at day 120 of gestation. Infection was established by inoculation of group B streptococci through a choriodecidual catheter. Amniotic fluid (AF) samples were collected serially before and after bacterial inoculation. Samples were analyzed by gel-substrate zymography and Western blot. A 92 kDa inactive form and 83 kDa active MMP-9 appeared in amniotic fluid 24 hr following infection. The amount/activity of 92 and 83 kDa forms showed a dependance on the inoculum dose and was higher when bacteria were present in amniotic fluid. Presence of high molecular weight dimers was characteristic of infection-initiated MMP-9 induction. The levels of 72 kDa type-IV collagenase (MMP-2) and tissue inhibitor of metalloproteinases (TIMP-1) were not modified by infection. These findings support the existence of a molecular link between intraamniotic infection and PROM. Presence of intrauterine infection and increased amniotic fluid cytokines correlates with higher amounts of MMP-9. Augmented extracellular matrix degradation will condition chorioamnion weakening and eventually the appearance of PROM.